Talking about Cannabis: Developing an Intervention for Family Members of Young Adults with FEP to Support Reduced Cannabis Use

Young adults (age 18-35) living with psychosis (YA-P; schizophrenia spectrum disorders) have
high rates of heavy cannabis use that are associated with long-term deleterious mental health and
functional outcomes. Those early in the course of psychotic illness are especially vulnerable to the
negative impact of cannabis on future recovery. There are no effective interventions that reduce
cannabis in this group. Clinicians agree that heavy cannabis use is a significant problem for YA-P
patients and report that effective, evidence-based interventions are sorely needed.
Families have been identified as effective and influential treatment allies for YA-P, but
often, cannabis is a highly contentious topic that can lead to interpersonal conflict. Such conflict
increases risk for psychotic relapse and is associated with non-change of substance use. The
goal of this study is to develop and pilot test an intervention for families of YA-P who use
cannabis to teach them skills to increase motivation among their YA-P to reduce their cannabis
use. Relevant skills from motivational interviewing and the community reinforcement and family
training interventions as well as psychoeducation centered on risks of cannabis to psychosis will
be core elements of the intervention. Phase 1 will focus on the development of the Cannabis
Conversation Skills for Families (CCSF) intervention material through the application of recently
collected qualitative (focus group) data. Specific adaptations will include: the development of
intervention content specific to YA-P such as education around the differential effects of THC
potency on psychosis, and the impact of cannabis misuse on psychosis intervention outcomes.
Materials will be iteratively adapted over the course of Phase 1 through pretesting the
intervention with 10 families of YA-P who frequently use cannabis. Phase 2 will include the
conduct of a randomized controlled pilot trial to assess feasibility, acceptability and preliminary
effectiveness of the CCSF with 40 relatives of YA-P who frequently use cannabis and are
engaged in coordinated specialty care. Participants will be randomly assigned to receive a 6-
session group delivered CCSF or treatment as usual (TAU) intervention and will be assessed at
baseline, and 3-month follow-up.
The specific aims are: 1) develop the CCSF for relatives of heavy cannabis using YA-P;
2) conduct a 1-arm pretest (n = 10) and counselor training trial; and 3) assess the feasibility,
acceptability and preliminary effectiveness of CCSF in a randomized pilot trial and assess target
mechanisms of expressed emotion, caregiver burden and self-efficacy.

Public health relevance
Project Narrative. Rates of cannabis use and disorders are high among young adults experiencing psychosis. Research indicates that continued cannabis use among this population is associated with a range of deleterious outcomes including decreased mental health engagement and medication management, increased rates of hospitalization, relapse and positive and negative psychotic symptoms. Given there are no identified evidence-based interventions to serve cannabis using young adults with psychosis, early intervention efforts with this population becomes an important public health objective.